Passive Monitoring of Walking Cadence as a Novel Tool for Aging and Cognitive Health Assessment

Project Summary
Despite enormous efforts, therapeutic clinical trials for Alzheimer’s disease (AD) have
largely failed, possibly because interventions are initiated too late into the disease
course when neurodegeneration has begun and is irreversible. Early detection of people
at high risk of AD is thus particularly important to help in the effort to develop prevention
and treatment options. We hypothesize that subtle changes in motor function may serve
as a potential biomarker of early signs of cognitive impairment. Tracking changes in
cadence will enable the assessment of potential parallel trajectories of motor/cognitive
decline and may prove to be an indicator of declining cognition. This study will leverage
a large collection of physical activity and cognitive assessment data, and derive novel
digital phenotypes from commercially available wearable devices (Aim 1). We will then
assess the correlation of these novel measures with declining cognitive function, and
develop advanced machine learning models to identify people at high risk to develop
cognitive impairment (Aim 2). Given the increasing popularity of wearable devices, the
knowledge and tools developed from the current project could be readily applicable to
the general population for the large-scale screening of cognitive health.

Public health relevance
Project Narrative Early diagnosis of cognitive impairment is essential to the development of new therapeutic strategies for Alzheimer's disease. Recent advances in wearable technologies provide a convenient way to record physical activity in the daily life. The objective of this project is to derive novel cadence variables from commercially available wearable devices and assess their potential as a passive monitoring tool for aging and cognitive health.